Project 2 - Center for Transformative Infectious Disease Research (CTIDR)

PROJECT 2 SUMMARY/ABSTRACT
Vector-borne diseases (VBDs) are a significant human health burden around the
world and are linked with extreme weather events and seasonal changes in
temperature and humidity in complex ways. In terms of vector biology, direct
linkages can be made in the laboratory setting between weather-related parameters
and aspects of vector competence for pathogen transmission. In the field, human
behavioral responses to weather fluctuations can also directly impact vector control.
Understanding these relationships in the context of modeling traditional parameters
and the interplay between humans, animals, and the environment is critical to
designing community-based interventions for vulnerable populations. This is the
second research project proposed as part of the P20 Center for Transformative
Infectious Disease Research (CTIDR). Here, we combine expertise in vectors,
pathogens, and genomics to lay the foundational groundwork for longer-term studies
by CTIDR on how weather and community practices affect public health, specifically
in the realm of weather-sensitive VBDs. In this project, we will have access to
samples from field sites at the front lines of emerging VBDs, in addition to state-ofthe art modeling and pathogen genomic technologies. We will draw on support from
the community engagement and data cores in order to integrate qualitative data in
our models and set up mechanisms to test the efficacy of future interventions. In
Aim 1: mosquito-borne diseases (MBD), we will build research capacity within the
United States by learning from experts at the University of Pretoria Institute for
Sustainable Malaria Control’s (UP ISMC) Remote Sensing for Malaria Control in
Africa (ReSMaCA). In Aim 2: tick-borne diseases (TBD), we will enhance our
understanding of the relationship between community practices, weather, and tickborne disease transmission. We will study the TBD pathogen dynamics between
people and the animals they closely interact with in the context of weather
parameters and demographic factors. We will use novel sequencing and
computational evolutionary approaches to identify signatures of zoonotic
transmission that can be linked back to weather-related behaviors and leveraged for
diagnostic development to directly benefit the community.